Ultra-high resolution 3D genome maps for multiple human tissues

Abstract
The diversity of human tissues and cell types is controlled by differential regulation of gene expression. Enhancers
are the primary units of gene expression control in humans, which physically interact with the target genes
to activate them. To understand the mechanism of transcriptional regulation, several landmarking consortia
have accumulated large amounts of genomic data. The NIH Common Fund GTEx project has revealed tissue-
specific gene expression and transcriptional regulation. The NIH Common Fund 4D Nucleome (4DN) project
has characterized 3D chromatin interactions in many human tissues and cell types. The ENCODE project and
the Roadmap Epigenomic project have profiled tissue-specific epigenomic states and annotated the regulatory
elements accordingly.
However, our understanding of human transcriptional regulation remains limited. A major challenge in studying
Enhancer-Promoter (E-P) interactions is that enhancers are often located tens to hundreds of kilobases distal to
their target genes, yet must physically interact with their target genes to activate them. Therefore, to understand
gene regulation in human, a necessary first step is to precisely map all E-P interactions. However, current 3D
maps of the human genome remain sparse and noisy and fail to detect the vast majority of E-P interactions. In
addition, the datasets generated from the Common Fund consortia are isolated in terms of cell types and tissue
types covered, how the data are stored, and the resolution of the genomic data, resulting in additional barriers for
integrative analysis.
Here we propose to combine the experimental approach, Region Capture Micro-C, and the deep learning
algorithms to accurately quantify E-P interactions. These results enhance the current 3D maps from 4DN and
ENCODE projects. We also plan to integrate experimental and imputed E-P interactions with NIH Common Fund
data in a knowledge graph. Our knowledge graph will support efficient cross-modality queries, graph visualization,
and customized computational modeling for investigating quantitative rules in transcriptional regulation. Not only
would this accomplishment have an enormous positive impact on the utility and usage of the Common Fund
datasets, but it would also help to promote open science and reproducible research in the areas of computational
genomics and data science.

Public health relevance
Project Narrative Enhancers are the key units of gene expression control in humans and activate genes across vast genomic distances, yet current 3D genomics methods cannot reliably capture enhancer-promoter interactions, thus hindering our understanding of transcriptional regulation. We plan to apply our recently developed Region Capture Micro-C to profile ultra-high-resolution contact maps for selected genomic regions from three human cell types, and then use our deep learning approach CAESAR to impute the ultra-deep genome-wide chromatin contact maps for diverse human tissues, which will provide accurate quantification of E-P interactions. These E-P interactions will be integrated with NIH Common Fund GTEx and 4DN datasets in knowledge graphs.